Project 2: Inter-Relationship of Disparities, the Microbiome, Innate Immune System and Immunotherapy Response in Endometrial Cancer

ABSTRACT – PROJECT 2
Endometrial cancer (EC) outcomes are among the most disparate in the US, with Black women suffering a much
lower 5-year survival rate than White women. Reasons for this are unclear but likely include an inter-relationship
between measurable social factors and biology, including potentially differences in the microbiome and the
immune system. Immune checkpoint blockade targeting programmed cell death protein 1 (PD-1) provides
significant clinical benefit in patients with EC. Two critical and inter-related factors that impact IO benefit are (1)
the gut and tumoral microbiome, and (2) the innate immune system (IIS) which is responsible for uptake and
clearance of monoclonal antibodies (mAbs), such as PD-1 inhibitors.
We were the first to evaluate differences in the microbiota of ECs, with the discovery that distinct microbiota
profiles differentiated ECs of Black vs White women. Furthermore, our preliminary studies show that Black
patients have a heightened IIS, which may result in lower exposures of mAbs due to enhanced clearance of the
mAbs by the IIS; and thus, Black women may need higher doses of mAbs (such as PD-1 inhibitors) to achieve
the same optimal therapeutic response as White women. Thus, we hypothesize that differences exist in the
tumor/gut microbiome and the IIS of Black women that will culminate in lower IO response and worse survival.
Using an ongoing North Carolina population-based study (Carolina Endometrial Cancer Study [CECS]) and a
prospective study of UNC EC patients undergoing PD-1 inhibitor therapy (PROMOTE), we will evaluate the EC
tumoral and gut microbiota and the IIS in Black and White patients in relationship to measurable social factors,
treatment response and survival outcomes. We will also perform more mechanistic studies in a unique germfree EC mouse model studying fecal microbial transplant (FMT) as a means to improve PD-1 inhibitor` treatment
response. This work will lead to the development of microbiota-directed interventions (i.e., FMT) to manipulate
bacterial presence and resolve microbial dysbiosis to improve PD-1 inhibitor efficacy and other clinical outcomes
in EC patients. In addition, the dose of PD-1 inhibitor treatment may need to be increased to optimize therapy in
women based on their IIS profiles. Ultimately this work will identify future actionable microbial and immune factors
and targets for improving outcomes and disparities in EC to be explored in subsequent clinical trials.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 Black women suffer a higher mortality from endometrial cancer (EC) than White women, and we hypothesize that this is due to differences in the tumor/gut microbiome and the innate immune system (IIS) that will align with decreased immunotherapeutic response and worse survival, as immunotherapy is critical in EC treatment. Thus, we will explore the inter-relationship of the tumor/gut microbiome and the IIS on EC progression and treatment through 1) an ongoing population-based study across the state of North Carolina (Carolina Endometrial Cancer Study [CECS]), 2) a prospective translational study in EC patients who are to undergo programmed cell death1 [PD-1] inhibitor treatment, and 3) via our newly created germ-free EC mouse model. Ultimately, we hope to develop microbiota- and IIS-directed therapies and interventions to overcome the growing public health concern of worsening outcomes and disparities in EC that will be explored in our future work and clinical trials.